The degradation of tau by selective autophagy

? DESCRIPTION (provided by applicant): This revised application is for the FOA, Promoting Research in Basic Neuroscience (PAS-15-029). Therefore this is a fundamental basic research proposal that is focused on understanding the role of Bcl-2-associated anthogene 3 (BAG3) in mediating selective autophagy and the turnover of tau in neurons and how these processes change during aging. Selective autophagy is part of a cell's protein quality control (PQC) system, which is the collection of cellular pathways that sense damaged proteins and facilitate their removal. PQC is essential for the maintenance of the appropriate, functional complement of proteins in a cell. Tau is a neuronally enriched multifunctional protein. Given the importance of tau in neuronal function, understanding the PQC processes which regulate phospho-tau species, as well as total tau levels, is of critical importance. There is a growing awareness that selective autophagy, i.e., the specific recognition and targeting of client proteins to the developing autophagosome is essential for effective PQC. Chaperones and co-chaperones, along with the autophagic machinery, are key PQC players in the process of recognizing and removing damaged proteins. The co-chaperone BAG3 is an important player in selective autophagy and thus a pivotal player in the PQC system. Recently we made the exciting discovery that in neurons BAG3 plays a significant role in directing endogenous, soluble tau to autophagy. This is of fundamental importance because in healthy neurons autophagy is constitutively active and plays a significant role in maintaining a functional proteome. BAG3 is a stress-induced protein that increases during normal aging. It has been suggested that during aging the change in cellular demands increases the use of autophagy to maintain protein homeostasis, and that BAG3 plays an essential role in this process. Indeed, it has been documented that during aging BAG3 levels increase in the rodent brain concurrent with an increased dependence on autophagy for proteostasis. Therefore, understanding the role of BAG3 in autophagy and how it functions to facilitate the clearance of soluble tau species is of fundamental significance. The overall hypothesis of this proposal is that selective autophagy plays a significant role in the clearance of tau and that BAG3 plays a central role in facilitating the degradation of soluble tau species through this mechanism. The specific aims of this proposal are: (1) To test the hypothesis that BAG3 modulates autophagy and tau turnover in situ and in vivo, and that during aging the dependence on BAG3 to facilitate autophagy and tau clearance increases, (2) To identify essential features of the BAG3-chaperone complex that mediate tau clearance, and (3) To characterize the mechanisms that regulate BAG3 expression and test their role in autophagy-based clearance of tau in neurons. Currently little is known about the role of BAG3 in mediating autophagy in neurons, as well as how it facilitates the turnover of tau; this application addresses these gaps in our knowledge.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the normal physiological processes that govern the clearance of damaged proteins in neurons is of fundamental importance. In this proposal we are focused on understanding the BAG-3 dependent mechanisms regulating autophagy and the the turnover of tau in neurons. This is a basic neuroscience question. In the future, results from these studies could provide foundational information for exploring disease-relevant issues.